Robust Mendelian Randomization Framework with Multi-Omics Data for Alzheimer's Disease and Related Dementias

Project Summary / Abstract
Alzheimer's disease (AD) is a progressive brain disorder that slowly destroys memory and other brain functions.
Modern large-scale high-throughput multi-omics data may provide a unique opportunity to detect omics biomark-
ers that are involved in the process of neurodegeneration in the preclinical and early clinical disease stages,
which is highly relevant for both early diagnosis and targeted interventions. Hidden confounding bias is a major
threat when using observational multi-omics data for detecting causal omics biomarkers for AD. Mendelian ran-
domization is a powerful causal inference approach to removing hidden confounding bias by leveraging omics
quantitative trait loci (xQTL) as instrumental variables (IV) to obtain unconfounded causal effect estimates. How-
ever, current MR methods may not be well suited for analyzing high-dimensional multi-omics data. First, xQTL
may have a horizontal pleiotropic effect on the outcome not mediated by the omics variables, violating the IV
exclusion restriction assumption. Second, the genetic associations between xQTL and omics variables might be
highly nonlinear and thus traditional linear exposure models might introduce bias and lose power; and there is a
lack of MR methods to account for the heterogeneity of AD etiology for personalized intervention. Third, current
MR methods may not handle high-dimensional omic exposures well. To address those pressing methodological
challenges, we will develop a new robust Mendelian randomization framework with multi-omics data using xQTL
as IVs to detect omics biomarkers causally associated with AD outcomes. We will construct uniformly valid and
informative conﬁdence intervals for the causal effect accounting for weak and IV selection errors in ﬁnite-sample
settings. We will develop machine learning algorithms to capture nonlinear structures of the omic exposure model
for more robust identiﬁcation and enhanced xQTL IV strength, and to estimate heterogeneous exposure effects
on the AD outcomes for personalized medicine. We will also develop a new double deconfounding framework for
the joint analysis of high-dimensional omics biomarkers in a common biological pathway. We will develop software
suitable for both high-performance computing clusters and cloud computing platforms following the Findability, Ac-
cessibility, Interoperability, and Reusability principle. Finally, we will apply the proposed methods to multi-omics
data in multi-ethnic cohorts including Washington Heights/Inwood Columbia Aging Project, the Alzheimer's Dis-
ease Sequencing Project Functional Genomics xQTL project and UK Biobank. Our proposal will provide the best
available analytical methods to date to resolve confounding concerns for multi-omics data, and will pave the way
towards innovative research on establishing causal relationships between omics biomarkers and AD outcomes.

Public health relevance
Project Narrative This project aims to develop and apply advanced causal inference methods and computational algorithms to em- power the analysis of large-scale genetic and multi-omics data in multi-ethnic and historically underrepresented populations. These methods will help identify causal omics-level biomarkers for non-invasive and accurate early diagnosis of Alzheimer's disease and related dementias in the preclinical phase, which might provide the best time window for early prevention and intervention.